Whole-brain fluorescence and brightfield imaging at single-cell level

DESCRIPTION (provided by applicant): The goal of this project is to develop an open and flexible imaging platform capable of rapid, 0.5- 5 μm pixel resolution image capture of large-area histology sections (up to 125 mm by 175 mm), in brightfield and by epi-fluorescence optical sectioning. The project involves state-of-the- art instrumentation development coupled with application programming interfaces (APIs) to provide users with a reliable, multi-purpose research instrument. The development of a high speed large format imaging system will dramatically accelerate investigations such as amyloid protein studies for Alzheimer's disease or the expression of immediate-early genes (IEG) in understanding of the cellular basis of cognition. The number of digital-imaging system options decreases dramatically as the size of histology sections outgrows 1 W 3 glass slides. Further, because the current vendors are concentrating on digitizing anatomic pathology, their systems tend to be closed and inflexible to accommodate the regulatory constraints on medical devices. The market opportunity that DMetrix has identified is a robust and reliable commercial imaging platform with the flexibility and customization options valued by research groups. The project is divided into two Phases, punctuated by a demonstration of quantitative criteria, related to instrument and software performance. The primary goal of Phase I is the demonstration of feasibility of the large-area, rapid imaging instrument for brightfield and epi-fluorescence. A second goal is an image-viewer application that allows practical interaction with terabyte image data sets as will be generated by the instrument. The Specific Aims of Phase II are selected to lead to a product launch at the conclusion of the project. The Phase II Aims include the development of a V6, six-imaging-module slide scanner, image- management software, and an advanced image-viewer application. Further, the work in Phase II leverages the core expertise of DMetrix, namely the development of fast, parallel image-capture instruments. A significant part of the Phase II effort will be directed at making the proposed instrument manufacturable at a minimum cost of goods sold (COGS) and optimized for serviceability. DMetrix has teamed on this project with an interdisciplinary group of academic experts from the University of Arizona. The University team includes Dr. Carol Barnes from the McKnight Brain Institute, Dr. Ted Trouard, Department of Radiology and Biomedical Engineering, and Dr. Gene Alexander, Director of the Brain Imaging, Behavior and Aging Lab in the Department of Psychology. These University of Arizona scientists represent a diverse sampling of the broad impact of the proposed imaging platform on neuroscience research.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the circuits in the brain responsible for cognition, emotion and action is a critical first step to developing treatments for important neurological disorders, such as Alzheimer's disease, Parkinson's disease, temporal lobe epilepsy, depression, and schizophrenia. Collectively, these disorders affect over 20 million Americans. Our long-range goal is to develop a system that has wide application across the field of neuroscience that will enable experiments impeded in the past by technological limitations, to span mouse models of disease to rat and nonhuman primate models of normal aging. This knowledge may bring us closer to optimizing neural function in health, and developing new therapies for patients disabled by neurological disease. Understanding the circuits in the brain responsible for cognition, emotion and action is a critical first step to developing treatments for important neurological disorders, such as Alzheimer's disease, Parkinson's disease, temporal lobe epilepsy, depression, and schizophrenia. Collectively, these disorders affect over 20 million Americans. Our long-range goal is to develop a system that has wide application across the field of neuroscience that will enable experiments impeded in the past by technological limitations, to span mouse models of disease to rat and nonhuman primate models of normal aging. This knowledge may bring us closer to optimizing neural function in health, and developing new therapies for patients disabled by neurological disease. __SpecificAimsTextDelimiter__ RESEARCH)PLAN:) Whole-brain)fluorescence)and)brightfield)imaging)at)single-cell)level) Introduction) The goal of this project is to develop an open and flexible imaging platform capable of rapid, microscopic image capture of large-area histology sections (up to 5" × 7"), in brightfield and by epi- fluorescence optical sectioning. The project involves state-of-the-art instrumentation development coupled with software and application programming interfaces (APIs) to provide users with a reliable, multi-purpose research instrument. The long-term goal of our development is a product capable of constructing micron-resolution, three- dimensional models of murine and primate brains. The envisioned product consists of: (1) an automated, fast, multispectral, brightfield and fluorescence large-area section imager, (2) software for rapidly visualizing terabyte-scale images in 2D and 3D as well as software tools for managing the imaging workflow and its results, and (3) APIs to enable the development of custom software required by individual research programs. Our product is intended to serve emerging needs in the research market. Figure 1 shows a schematic view of the project's organization. This project will involve an interdisciplinary group of academic experts from the University of Figure 1. Organization of the Fast Track project. The Arizona and a University of Arizona spin-off project includes a gradual development of two related company, DMetrix, Inc. The University team imaging modalities as well as software components common to both. Note the transition to faster, parallel includes Dr. Carol Barnes from the McKnight Brain imaging of increased-area substrates in Phase II. Colored Institute, Dr. Ted Trouard, Department of Radiology circles indicate excitation wavelengths (405, 488, 561, and and Biomedical Engineering, Dr. Gene Alexander, 635 nm) in the epi-fluorescence column and red, green, and Director of the Brain Imaging, Behavior and Aging blue color channels in the brightfield column. AF: Lab in the Department of Psychology, and Dr. autofocus; TD: tissue detection; 3D: three dimensional. Michael Descour, College of Optical Sciences and DMetrix co-founder. The DMetrix team includes technology developers and engineers who have a demonstrated track record of converting technology licensed from the University of Arizona into a leading, award-winning product. A Specific)Aims) A.1 Phase)I)Specific)Aims) The primary goal of Phase I is the demonstration of feasibility of the rapid large-area imaging instrument for brightfield and epi-fluorescence. A secondary goal is an image viewer application that allows practical interaction with multi-terabyte image data sets as will be generated by the imager. At the end of Phase I, DMetrix will deliver to its University of Arizona partners an "alpha" prototype of the instrument and software. The two Phase I Specific Aims are: Specific Aim 1: Build and demonstrate quantitative performance criteria on a fast, large-section brightfield and epi-fluorescence imaging system capable of scanning substrates up to 4" × 5" in size (100 mm × 125 mm) using a single microscope objective. The Milestones associated with Specific Aim 1 encompass measures of image quality, lateral and axial image resolution, and imaging time. Specific Aim 2: Demonstrate an image-viewing application capable of rapid display of terabyte, multi-color optically sectioned representations of brain- tissue sections. The Milestones associated with Specific Aim 2 emphasize quantitative measures of file handling and image-navigation speed. A.2 Phase)II)Specific)Aims) Phase II will emphasize improvements to the instrument and 3D viewing and registration software in a continuation of the efforts of Phase I. A significant part of the Phase II effort will be directed at making the instrumentation manufacturable at a minimum cost of goods sold (COGS) and optimized for serviceability. Accordingly, the Phase II Specific Aims are: Specific Aim 1: Build and demonstrate a large-section brightfield and epi- fluorescence imaging system that is an order of magnitude faster for the largest sample sizes than the Phase I prototype, thanks to an array of six microscope objectives imaging a section simultaneously and continued instrument optimization. Specific Aim 2: Develop an image management database to track images and metadata as well as an application programming interface (API) to allow read/write access to the database. Specific Aim 3: Develop an enhanced version of the image-viewing application of Phase I that allows 3D interaction and registration of sub-micron resolution, ultra-large format images. Phase II product development work will emphasize a modular approach. The benefit to our customers will be a more flexible, upgradable platform. The benefit from our perspective will be a more manufacturable and serviceable product. labeling with Arc (green) and B Background)and)Significance) zif268 (red) antisense riboprobes DMetrix's product-development roadmap began with a brightfield array- demonstrates distinct pairs of microscope for fast scanning of glass slides, followed by a multispectral intranuclear foci for Arc imager. Our approach is to expand our product line in innovative directions and zif268. Arc intranuclear while leveraging previously developed, familiar technology. The large-area foci are indicated by short whole-brain imaging system proposed here adheres to that strategy. arrows (a, c, d). The zif268 What we are proposing here is an imaging system consisting of intranuclear foci in Part (d) are hardware and software that is designed to be open and configurable by a indicate1d1 by the longer scientist yet have the robustness and reliability of a commercial product. arrows. Current options for large-area, microscopic imaging are developed ad hoc by academic research groups. Instrumentation tends to be based on conventional microscope equipment and is not optimized for speed or reliable operation. Large microscope vendors do not pursue this opportunity because they perceive the market as relatively small compared to their sales of conventional light microscopes. The only solution is for a small company with experience in precision high-speed imaging and handling of ultra-large image data sets to work with leading researchers to develop a system that combines robust instrument operation with flexibility when it comes to handling and analyzing the image data that it produces: A perfect match for the research community and the associated market. We begin this section of the proposal with a review of two immediate applications of the proposed instrumentation. These applications involve significant scientific and technical promise yet are blocked from further progress by the absence of a commercial solution such as we intend to develop. B.1 Applications)of)the)proposed)product)and)needs)to)be)filled) B.1.1 Cellular)basis)of)cognition) An understanding of the cellular basis of cognition will require a more complete knowledge of local brain circuits and how their interactions generate the behaviors of interest. The advent of electrophysiological Figure 2. Subcellular distribution of Arc RNA revealed by FISH and confocal microscopy. Single optical plane confocal images are from the CA3 region of rat hippocampus. Parts (a-c): Sections were subjected to FISH with a digoxigenin- labeled Arc antisense probe, which was detected with a Cy-3 fluorescent substrate (red). Part (a): Characteristic Arc intranuclear foci. Part (b): Cytoplasmic- only labeling of Arc RNA. Part (c): An Arc intranuclear foci/cytoplasmic double- positive cell. Part (d): Double-